The Role of Selective A3 Adenosine Receptors Activation in Myocardial Protection in donation After Circulatory Death Heart Transplantion

PROJECT SUMMARY/ ABSTRACT: URBAN PROJECT
Despite continued expansion in the use of donor hearts following brain death, there remains an
unacceptable shortfall in the supply of suitable donor hearts compared to the demand from increasing recipient
numbers on transplant waitlists. Donation after circulatory-determined death (DCD) is emerging as an
alternative pathway to traditional donation after brain death. DCD heart transplantation has been made
possible by technological developments of reanimation and preservation. In donation after brain death donors,
artificial ventilatory and hemodynamic (blood flow) support is used to keep organs in a fully functional state
before transplantation. In DCD donors, an absence of respiratory and circulatory function deprives the organs
of oxygen for a variable period of time before organ recovery, which increases the challenges in maintaining
viability.
The current reanimation technique used once the heart ceases function is to take the heart out of the donor
body (ex-situ) and connect it to a heart and lung machine. A recently developed alternative is to restore
circulation inside the donor body (in-situ) by connecting the circulation of the donor to the heart and lung
machine. This technique of inside the body heart reanimation, in contrast to outside of the body reanimation,
has an added benefit of increasing the quality of other donor organs (liver, kidneys) and allows for an
assessment of heart function prior to transplantation in a more natural environment. An undesirable effect of
this technique, attributed to the use of fully oxygenated blood, causes structural damage to the heart and
compromises function. We hypothesize that using an advanced cardioprotective solution during initial
perfusion would minimize damage to the myocardium.
Our long-term objective is to develop an optimal technique for inside of the body reanimation and
preservation of organs in donation after circulatory determined death. Our specific aims are to demonstrate
improved heart function and decreased myocardial structural damage in organs initially perfused with
cardioprotective solution in comparison to organs reanimated with fully oxygenated blood. To achieve our
aims, we will use a novel porcine model of low-oxygen circulatory arrest. We will assess the function (via
echocardiography and hemodynamic measurements), and structural damage via special blood and tissue
analysis) in donor organs perfused inside of the body with standard technique using fully oxygenated blood.
These will be compared to the results of 5 organs perfused initially with cardioprotective solution.
We anticipate that successful translation of our technique into clinical practice could increase the heart
transplantation activity in our region by 20% by improving availability of donor organs. Expanding the donor
pool would also increase the accessibility of organs to ethnic and racial minorities in our region as well as
nationally.

Public health relevance
PROJECT NARRATIVE: URBAN PROJECT Not applicable